Real time neurofeedback, its neurotransmitter underpinnings, and therapeutic effects, in clinical high risk individuals

Clinical high risk (CHR) for psychosis states are symptomatic, dynamic periods that occur before
psychosis onset and are subjects of intensive research. The focus on CHR is driven by evidence of behavioral
and brain level impairments in many individuals experiencing their attenuated psychotic symptoms which are
similar to those found in first episode and chronic schizophrenia (SZ): our work, and that of others, demonstrated
that CHR individuals show deficits in both brain function and cognition reminiscent of those found in SZ. For
example, increased default mode network (DMN) connectivity found in SZ was also identified in CHR. The CHR
period offers the most hope for mitigating or preventing disease development yet effective treatment options are
still lacking.
The overarching goal of this R61/33 study is early efficacy testing of the real-time functional MRI-based
neurofeedback (rt-NFB), aided by mindfulness (rt-NFB+M), to impact both brain connectivity and clinical and
neurocognitive (NP) outcomes. In the R61 phase, we will examine the efficacy of rt-NFB+M targeting the DMN
to reduce medial prefrontal and posterior cingulate cortex (MPFC-PCC) hyperconnectivity and to increase
MPFC-dorsolateral prefrontal cortex (DLPFC) anti-correlations in CHR subjects who will be randomly assigned
to either real-rt-NFB+M (N=24) or sham/control -rt-NFB+M (N=24) condition. Thirty healthy controls scanned
once will serve as an additional control group. Neurotransmitters in MPFC and DLPFC will also be assessed
using magnetic resonance spectroscopy to relate cellular level measures to brain network measures. MPFC-
PCC connectivity reductions and MPFC-DLPFC increased anticorrelation, post-NFB, in the real rt-NFB+M
group, will be the R61 GO criteria. In the R33 phase, we will replicate R61 results in an independent sample
of 51 CHR in the real-fMRI NFB+M condition, compare the effects of rt-NFB+M (N=51 CHR) versus meditation
only (N=30 CHR), examine dose-response over 4 sessions, and the relationship between network connectivity
and glutamate (Glu) and GABA changes, as well as clinical and neuropsychological changes, especially in
working memory (WM) and attention, post-intervention, in both rt-NFB+M and in the meditation only group. This
proposal builds on our successful use of rt-NFB in SZ to modulate the DMN connectivity and mitigate symptoms.
As one of the first in the field, we demonstrated that rt-NFB targeting the DMN reduced its hyper-connectivity in
SZ which; in turn, was associated with auditory hallucinations reduction after rt-NFB. Increased MPFC-DLPFC
anticorrelations were also observed and associated with increases in MPFC GABA in a separate study.
Furthermore, we have observed that increases in DMN-DLPFC anticorrelations due to pharmacological or
behavioral interventions are associated with improved WM and attention. Since our preliminary data suggest that
SZ with the least abnormal brain patterns benefited most from our rt-NFB intervention, we believe that adopting
the rt-NFB in CHR will be highly effective in altering the disease trajectory.

Public health relevance
This application proposes to examine whether rt-fMRI neurofeedback (rt-NFB), combined with mindful meditation (rt-NFB+M), and directed at the default mode network (DMN) in clinical high-risk individuals can reduce DMN connectivity (between posterior cingulate cortex (PCC) and the medial prefrontal cortex (MPFC)) and increase anticorrelations between MPFC (a hub of DMN) and dorsolateral prefrontal cortex (DLPFC; a hub of central executive network). In the R61, we will use rt-fMRI NFB+M to demonstrate brain target engagement: DMN connectivity reduction, MPFC-DLPC anti-correlation increase, post-rt-NFB+M, and assess GABA, glutamate, and other magnetic resonance spectroscopy (MRS) neurochemicals in the MPFC and DLPFC using resting state fMRI localization. In the R33, we will 1) replicate the R61 results in a larger sample; 2) examine dose-response over four sessions of rt-NFB +M; 3) test four sessions of NFB +M against four sessions of mindfulness only; 4) show cognitive and clinical improvement, post- rt-NFB +M; 5) relate the clinical and neuropsychological changes to brain changes at both cellular and network levels, post-rt-fMRI, in rt-NFB +M group and in meditation only group, co-localize resting state and neurochemical data to relate cellular and network-level processes, pre- and post-rt-NFB.